Cross-disciplinary training in translational neuroimaging of ADRD

PROJECT SUMMARY
Alzheimer’s disease and related dementias (ADRD) are a leading cause of neurological disability, causing
devastating impairments in cognition and functional capacity . Although there has been considerable progress
in identifying mechanisms underlying ADRD, and symptomatic treatment is available for some ADRD, there is
urgent need for greater understanding of the mechanisms underlying these dementias to identify potential
treatment targets and to contribute to successful treatment trials. Because of its ability to resolve brain
structure and function noninvasively, neuroimaging has become a leading strategy used for translational
research in ADRD and a prominent biomarker strategy for clinical differential diagnosis of ADRD, for defining
preclinical stages of ADRD, and for evaluating for target engagement and therapeutic responses in trials.
Modern neuroimaging is an inherently interdisciplinary field combining expertise in physics, chemistry,
engineering, computer science, neuroscience, and statistics to localize and quantify a large array of metrics
reflecting the molecular, cellular, structural, functional, and physiological properties of the central nervous
system. Additional expertise in topics such as genomics, proteomics, metabolomics, neuropharmacology,
psychology, and neuromodulation are also required to optimally combine or apply neuroimaging with other key
areas in ADRD research. Finally, because of its multidimensional nature, neuroimaging is a “big data” field
requiring expertise in informatics and data management. The University of Pennsylvania has a longstanding
track record of innovation and translation in biomedical neuroimaging in ADRD, and supports state-of-the-art
instrumentation for in vivo MRI, PET, CT, and optical imaging in both humans and preclinical models as well as
extensive expertise and resources in image processing and spatiotemporal statistics.
In response to PAR-21-112 the proposed “Cross-disciplinary training program in translational neuroimaging of
ADRD” will draw predoctoral and postdoctoral trainees from both biological and quantitative science
backgrounds who are seeking a research career focusing on neuroimaging in ADRD. A core curriculum
covering neuroimaging methods will be combined with specializations in 1) imaging studies of disease
mechanism, 2) imaging biomarkers and neuroimaging trials, or 3) statistical and computational approaches to
neuroimaging data. A diverse faculty with outstanding track records of research and mentoring in neuroimaging
and related fields will participate, with each trainee receiving dual mentorship from faculty with complementary
expertise. The aims of the proposed training program are 1) to train the next generation of ADRD
neuroimaging researchers, 2) to increase diversity in neuroimaging research through efforts to increase
diversity in both program trainees and program faculty, 3) to expand local ADRD neuroimaging research
through participation of training faculty with related domain expertise, and 4) to provide training in the
Responsible Conduct of Research and Experimental Rigor, particularly as it applies to neuroimaging.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease and related dementias (ADRD) are a leading cause of neurological disability. Because of its ability to resolve brain structure and function noninvasively, neuroimaging has become a leading strategy used for translational research in ADRD and a prominent biomarker strategy for clinical differential diagnosis of ADRD, for defining preclinical stages of ADRD, and for evaluating for target engagement and therapeutic responses in trials. This cross-disciplinary training program in translational neuroimaging of ADRD aims to leverage the University of Pennsylvania’s longstanding track record of innovation and translation in biomedical neuroimaging in ADRD to increase training for the current and emerging generation of researchers in neuroimaging approaches that have potential to impact cognitive impairment and dementia including neuropathology, translational research, drug discovery, and clinical trials of ADRD.